Computational tools and quantitative analyses of genome structure evolution

ABSTRACT
Understanding the forces that drive structural changes in the genome remains a key challenge in genetics and
evolutionary biology. Since the earliest days of genetics, scientists have understood the vast implications that
structural variation has on phenotypes. Chromosomal variation is ubiquitous across nature. It has been shown
to play a role in several biological processes and is associated with multiple traits, including number of
offspring, disease states, and the regulation of gene expression. Yet, despite this ubiquity and importance,
several longstanding questions about the evolution of structural variation remain unanswered. Over the next
five years, my lab will advance two parallel and complementary research lines that focus on two major features
of the genomic landscape: chromosome inversions and sex chromosomes. First, my group will investigate
the evolutionary forces maintaining inversions and the specific mutations within inversions that underlie
important phenotypes. To this end, I will create and deploy a full-featured open-source software package
that simulates whole chromosomes that carry polymorphic inversions and use it to quantify evolutionary
forces acting on inversions in the malaria mosquito Anopheles gambiae. This proposed computational
infrastructure will deepen our understanding of the biology of inversions and their role in processes like
adaptation and speciation, and will motivate further work by allowing the rapid simulation of genome-scale data
with chromosomal variation. A second research line uses comparative and population genomics to test
theoretical predictions on the evolution of sex chromosomes, perhaps the most dynamically evolving
region of the genome. I will focus on two independently evolved sex-chromosome systems in Solanum (a
speciose plant genus of agricultural importance and considerable genomic resources), to study the mode and
tempo of sex chromosome divergence. I will produce chromosome-level genome assemblies for two dioecious
species (i.e., those with separate male and female individuals), characterize their sex chromosomes, and use a
comparative approach to test for gene movement on and off the sex chromosomes. Further, I will search for
two key features of the sex-linked regions predicted by theoretical models: an enrichment of sex-biased gene
expression and an accumulation of sexually antagonistic polymorphism. My research will leverage the benefits
of working with evolutionarily recent sex-chromosome systems, gaining a unique perspective on the origin of
sex and the dynamics of sex-linked genomic regions, and learning about the conditions that affect the evolution
of recombination suppression, subsequent sex-chromosome divergence, and potential degeneration. By
developing computational tools necessary for genomic analysis and by testing core hypotheses of the
evolution of large genomic features, this research program will make important strides in our understanding of
how and why the structure of the genome evolves.

Public health relevance
PROJECT NARRATIVE Chromosomal variation plays an important role in several biological processes and is associated with multiple traits, yet the forces driving and maintaining this variation are not fully understood. This proposal tackles challenges regarding the evolution of two major features of the genomic landscape: chromosome inversions and sex chromosomes. By developing computational tools necessary for genomic analysis and by testing core hypotheses of the evolution of large genomic features, this work will make important strides in our understanding of how and why the structure of the genome changes through evolutionary time.